Roles of non-Coding RNAs in Programming Lymphocyte Differentiation and Function

The Integrative Immunobiology Section is dedicated to deciphering gene expression programs that direct cell fates in the hematopoietic and immune systems, since perturbations to their genetic program underlie many diseases such as cancer, immunodeficiency, autoimmunity, allergy and infectious diseases. We seek knowledge that will provide insights for understanding these diseases and the parameters for effective immune responses. As one tractable and relevant model system, we are taking advantage of CD4+ T helper cell differentiation since many research tools are available for this system and much is already known about its core transcriptional program and signaling pathways. However, relatively little is known about post-transcriptional control of gene expression and the roles of non-coding RNAs in immunity. One major focus of this project is a class of endogenous small untranslated RNAs, called microRNAs (miRNAs), that partner with Argonaute (Ago) proteins to form effector RNA-induced silencing complexes (RISCs) that recognize cognate mRNA targets and reduce their expression post-transcriptionally. It became evident that miRNAs are required for B and T lymphocyte differentiation when miRNA biogenesis was blocked by conditional ablation of the miRNA processing enzyme Dicer in genetically engineered mouse models. In one dramatic example, we found that Dicer-deficient T helper cells differentiated under Th2-polarizing conditions were reprogrammed such that they exhibited features of Th1 cells. In Dicer-deficient embryonic stem cells, we found evidence that the miR-290 family of microRNAs can dramatically impact the epigenetic landscape genome-wide thus providing insights on how post-transcriptional regulation might contribute to reprogramming of adult somatic cells into embryonic-like induced pluripotent stem (iPS) cells. Similarly, in Th17 cells, we determined that miR-155 can reprogram the pattern of histone methylation genome-wide. Recently, we have expanded our research to identify novel long non-coding RNAs (lncRNAs) that are expressed in lymphocytes using a technique called RNA-seq and will endeavor to determine their roles in immunity. Previously, we successfully combined mouse genetics and genomics to systematically determine the impact of non-coding RNAs on the transcriptome. We will continue with this approach to integrate miRNAs and lncRNAs into maps of regulatory networks that orchestrate gene expression in lymphocytes. To accomplish our goals we employ state-of-the-art genomic methods enabled by massively parallel sequencing and analyses thereof using high performance computation. We routinely perform deep sequencing for a variety of genomic applications (eg. RNA-seq, ChIP-seq, ATAC-seq, CLIP-seq) with the goal of understanding how cells in the immune system dynamically interpret the genetic code within their DNA and RNA in order to fulfill their biological destinies. This past year, we have been busy generating, analyzing and mining our data; we formulated a number of interesting hypotheses; and we are intensively testing them experimentally in the laboratory. We surmounted a number of technical challenges and are currently concluding some of our work for publication.